Administrative Core

PROJECT SUMMARY/ABSTRACT
The purpose of the Administrative Core is to support the translational research objectives of our SPORE in
Bladder Cancer by serving as the organizational hub, optimizing collaboration among SPORE investigators
within and outside the Memorial Sloan Kettering Cancer Center (MSK). The specific aims of the Administrative
Core are (1) provide coordination for all educational and scientific activities of the SPORE, and (2) provide
centralized administrative support of day-to-day activities to all the components of the SPORE: research
projects, cores, and developmental research and career enhancement programs. The services centralized in
the Administrative Core provide the following administrative and communications infrastructure that serve all
components of the SPORE.
 Financial Management: serve as the centralized SPORE budgetary coordinator and financial manager
 Grants Administration: serve as administrative liaison to the National Cancer Institute, ensuring the timely
submission of all required reports and compliance with institutional and federal regulations
 Editorial Services: provide editorial services for manuscript publication and grants coordination
 Coordination of the Developmental Research Program and Career Enhancement Program: responsible for
the administration of these programs, including the distribution of Requests for Applications
 Meetings Coordination: organize the scientific review of ongoing SPORE research projects, cores, and pilot
projects as well as the annual solicitation of new pilot projects
 Communication: foster communication and collaborative research within our SPORE as well as with other
SPOREs in Bladder Cancer and the wider scientific community
 Data Management: support the overall data management capabilities of the SPORE and facilitate the
sharing of genomic and other molecular data and linked clinical annotation in a manner that assures patient
privacy and compliance with all Federal and State regulations
The Administrative Core will be led by Dean F. Bajorin, MD, and David B. Solit, MD, Principal Investigators of
the SPORE in Bladder Cancer. They will share overall authority for the scientific and administrative decision-
making and for the day-to-day running of the program. The Administrative Core will also include personnel
trained in financial management, operations, grants administration, medical editing, and data management.
Core members will work as a team to ensure the effective financial and administrative management of the
SPORE.

Public health relevance
PROJECT NARRATIVE The Administrative Core will provide centralized scientific and administrative oversight and management of the SPORE in Bladder Cancer at Memorial Sloan Kettering Cancer Center to facilitate the accomplishment of the translational research objectives of the program.